Investigation of Epigenetic Dysregulation in Lupus NK Cells

PROJECT SUMMARY
The overarching goal of this proposal is to systematically characterize an epigenetically distinct natural
killer (NK) cell population with hypoacetylated histones. This NK cell subset is reduced in frequency in systemic
lupus erythematosus (SLE) patients with increased disease activity. We will test the hypothesis that this NK cell
subset, which we term “NKSLE cells”, has a distinct cell surface molecule profile, and is functionally different from
other NK cells in cytolytic capacity and cytokine secretion upon activation. We will further examine if NK cell
functions can be altered by experimental manipulation of histone acetylation. Our data will lay a strong foundation
for future epigenomic studies on specific genes or genomic loci pivotal for lupus pathophysiology. The advent of
single-cell technologies has greatly accelerated our understanding of immune system heterogeneity. Increasing
evidence supports a compelling model in which pathologically important cells in SLE may represent only a small
fraction of the highly complex immune system. This proposal builds upon this innovative concept, and will
leverage cutting-edge technologies to interrogate the epigenetic and proteomic heterogeneity of NK cells, and
their complex relationships. In Aim 1, we will employ highly multiplexed mass cytometry to monitor a broad array
of functionally important NK cell markers, such as activating and inhibitory receptors, cell adhesion molecules,
and those indicative of cytotoxicity activity, and histone acetylation abundance in individual NK cells. We will first
benchmark NK cell heterogeneity in healthy blood donors, with a goal to identify cellular features associated with
global histone acetylation level. Next, we will extend the analysis to SLE patients, whose NK cell compartments
show reduced representation of cells with hypoacetylated histones. This study will reveal the phenotypic and
functional characteristics of NKSLE cells. In Aim 2, we will investigate the functional differences between NK cells
with differential histone acetylation content. Cytotoxicity and proinflammatory cytokine secretion are key
immunological functions mediated by NK cells during a viral infection. Mass cytometry will be utilized to examine
how differential histone acetylation abundance in individual NK cells is correlated with the degree of their immune
response upon activation measured by degranulation markers, and cytokine production. Our analysis will first
focus on NK cells isolated from healthy volunteers, and subsequently extend to those from lupus patients to
better understand the clinical significance of NKSLE cell reduction in lupus. Lastly, as opposed to genetic
mutations that are generally refractory to therapeutic interventions, epigenetic phenomena are largely reversible,
making them attractive targets for developing new drugs. We will investigate the plasticity of NK cell functions
by pharmacologically manipulating histone acetylation. Together, our proposal will provide new insights into the
biological and pathological significance of histone acetylation in NK cell molecular and functional phenotypes.
Our data will be valuable for future studies on lupus and other human diseases in which NK cells play important
pathological roles.

Public health relevance
PROJECT NARRATIVE We will characterize a novel natural killer (NK) cell subset with unique histone acetylation pattern, and reduced in frequency in the peripheral blood of patients with systemic lupus erythematosus (SLE). Our proposal will provide valuable insights into the molecular regulation of SLE pathophysiology, and studies of other human diseases where NK cells play pivotal pathological roles.